OCT Measurement of Trabecular Meshwork Function In Vivo

Project Summary/Abstract
Glaucoma is a major cause of blindness and current treatments are insufficient. A major and the only treatable
risk factor for glaucoma is elevated intraocular pressure (IOP), which is usually due to trabecular meshwork (TM)
dysfunction. Remarkably, techniques for directly assessing the most relevant measure of TM function, i.e. outflow
facility, have not changed for 60+ years, are patient-unfriendly, and are rarely used clinically. Our prior work has
established a correlation between TM stiffness and outflow facility in human and mouse eyes, strongly implicating
TM stiffness as a surrogate measure of TM function.
Here it is proposed to develop and validate a novel OCT-based method to measure TM stiffness in patients as
an indirect indicator of TM function, an approach we term “21st century tonography”. The key idea is to image
the TM and Schlemm’s canal as IOP is manipulated. Based on these images, unbiased (automated) OCT image
segmentation will be used to quantify the change of Schlemm’s canal luminal size as a function of IOP, and then
engineering analysis techniques (inverse finite element modeling) will be employed to quantify the stiffness of
the TM in the living eye.
The proposal’s preliminary data strongly suggest that this approach is feasible. Thus, the overall objective is to
validate the approach, which will be achieved through two specific aims. The first uses mouse models and the
second uses human eyes. In Aim 1, we will build on our extensive experience in imaging the mouse outflow tract
with OCT in normotensive animals and in two clinically-relevant established models of ocular hypertension. The
resulting TM stiffness measurements will be validated against direct measurements of TM stiffness using our
established protocol based on atomic force microscopy, and against longitudinal IOP and outflow facility
measurements. In Aim 2, we will carry out analogous studies in human eyes, first using perfused human anterior
segments where the tissue can be extensively manipulated, and then moving to clinical studies in patients with
ocular hypertension/early glaucoma. An important aspect of all proposed studies is that the effects of a clinically-
available rho-kinase inhibitor (netarsudil) on TM stiffness, TM function, and IOP will be longitudinally assessed,
strengthening clinical relevant and impact. It is expected, as suggested by the strong preliminary data, that the
proposed OCT-based approach to measuring TM stiffness and TM function will be shown to be valid.
This project is highly innovative, since it will create a novel, non-invasive tool to interrogate TM function in human
subjects, the first such tool since the introduction of tonography six decades ago. Such a tool will be useful in
multiple contexts, including: (1) basic science studies of TM function and physiology; and (2) longitudinal
evaluation of novel emerging treatments to repair TM function, including small molecule-based therapies, gene
therapy approaches for restoring TM function, and stem cell-based therapies for the TM.

Public health relevance
Project Narrative Glaucoma is the second leading cause of blindness worldwide, with elevated pressure in the eye as its primary risk factor; indeed, all current treatments try to lower eye pressure, but are often unsuccessful. In many glaucoma patients, we know that the tissue within the eye that controls eye pressure, the trabecular meshwork, is stiffer and functions poorly. Here we develop an approach, using clinically-available non-invasive imaging, to measure trabecular meshwork function with the goal of assessing treatment efficacy in glaucoma patients and improving our understanding of how the trabecular meshwork fails in many types of glaucoma.